HIGH-SPEED MULTICHANNEL SPECTROPHOTOMETER

A number of commercial multichannel spectrophotometers using charge-coupled devices have recently been developed for general use in biomedical research. We have explored the possibility of improving both the speed and the accuracy of such instruments by exploiting other new devices.